A Translational Informatics Framework to Mine Efficacy and Safety of Dietary Supplements

PROJECT SUMMARY
Most U.S. adults (77%) take dietary supplements (DS) and 87% of them express overall confidence in the
safety, quality and efficacy of DS. However, DS are not always safe. DS information is scattered in biomedical
literature, social media, and FDA spontaneous reporting system. Thus, to optimize the proper and safe use of
DS, there remains a critical need to develop informatics framework with innovative tools and resources to enable
us better understand efficacy and safety of DS through multimodal data sources. Built upon our prior project, the
objective of this renewal application is to create an enriched DS knowledge base (eDISK) and to develop a
translational informatics framework (iDISK-Mine) with innovative informatics approaches to facility DS research
using real-world, multi-site EHR data and. We will expand our prior work in two major aspects: (1) Expand our
scope to both efficacy and safety (focus of the prior project) of DS using multimodal data sources to enrich our
current DS knowledge base (i.e., eDISK); and (2) Develop and evaluate a translational informatics framework to
facilitate DS research using multi-site real world EHR data. We propose the following Specific Aims: (1) Create
eDISK by integrating DS efficacy and safety from multimodal data sources; (2) Develop a translational
informatics framework (iDISK-Mine) to facilitate EHR-based observational DS research; and (3) Evaluate the
generalizability and utility of iDISK-Mine on the multi-site EHR data of depression patients. This is the first project
to develop a translational informatics framework to advance our DS knowledge using multimodal data sources
and enable us to understand how patients (e.g., depression patients) use DS using the real-world EHR data.
The successful accomplishment of this project will deliver a novel framework with valuable tools and resources
for DS clinical and translational research.

Public health relevance
PROJECT NARRATIVE Built upon our prior project, the objective of this renewal application is to create an enriched DS knowledge base (eDISK) and to develop a translational informatics framework (iDSIK-Mine) with innovative informatics approaches to facility DS research using real-world, multi-site EHR data. This is the first project to develop a translational informatics framework to advance our DS knowledge using multimodal data sources. The successful accomplishment of his project will deliver a novel informatics framework with valuable tools and resources for identifying DS efficacy and safety from multimodal data sources, and enable us to understand how patients (e.g., depression patients) use DS using the real-world EHR data.